Expansion and sustainability of University of Pretoria (UP), South Africa research administration services and resources for NIH/ NIAID grants

PROJECT SUMMARY To expand the current pre‐ and post‐award services offered by the University of Pretoria to provide state‐of‐the‐art research support on NIH/ NIAID grants to UP researchers, collaborating university partners and regional research administrators

Public health relevance
PROJECT SUMMARY EXPANSION AND SUSTAINABILITY OF UP RESEARCH ADMINISTRATION SERVICES AND RESOURCES FOR NIH/ NIAID GRANTS Project aim: To expand the current pre‐ and post‐award services offered by the University of Pretoria to provide state‐of‐the‐art research support on NIH/ NIAID grants to UP researchers, collaborating university partners and regional research administrators Objectives: 1. Develop pre‐award, post‐award and institutional governance competencies of UP research administrators 2. Develop sustainable resources and services to assist UP researchers and faculty research administrators 3. Develop sustainable resources and build capacity of regional research administrators